Bone Marrow Endothelial VEGFR3 Regulation of Leukocyte Trafficking in Myocardial Infarction

Cardiovascular disease (CVD) accounts for more annual deaths in the US than cancer and lung disease
combined highlighting the pressing need for novel therapeutic interventions in this setting. Recent success of
the CANTOS trial supports the notion that interventions to attenuate CVD-induced inflammation may hold the
key to future therapeutics. A body of evidence from us and others have demonstrated that CVD induces
emergency hematopoiesis in the bone marrow (BM) inciting the release of leukocytes which travel to infarct or
atherosclerotic tissue worsening pathology, a phenomenon that has been described in humans. Our
unpublished work found that models of CVD induce a pro-angiogenic phenotype in the BM vasculature which
drives leukocyte release into the blood in an incompletely understood process. We observed elevated
circulating vascular endothelial growth factor (VEGF) levels in mice with CVD. Interestingly, vascular
endothelial growth factor receptor 3 (VEGFR3) is highly expressed in the sinusoidal niche of the marrow, the
vascular compartment where hematopoietic cells and leukocytes reside. VEGF-C/VEGFR3 signaling has been
reported to regulate transendothelial migration of cells across lymphatic endothelium during cancer-induced
inflammation, a process reminiscent of the gate-keeping function of BM sinusoids. My preliminary data
examining neutrophil intravasation by time-lapse intravital microscopy in a sepsis-like model of BM
inflammatory stress found that neutrophil entry increases at specific sites which we term “EC gates” with no
change in the number of gates suggesting that leukocyte intravasation likely occurs at specialized sites of the
endothelium. Thus, we hypothesize that endothelial VEGFR3 signaling regulates leukocyte trafficking through
“gates” within the BM sinusoidal endothelium during inflammatory stress. We will test this hypothesis by
investigating the relationship between inflammatory stress and EC gate activity using time-lapse intravital
microscopy to track neutrophil intravasation frequency, the frequency of distinct “gates” of entry and the ratio of
intravasation events to gates across LPS and control groups. We will measure VEGFR3 signaling in sorted BM
endothelial cells and test whether inhibition of VEGFR3 inhibits EC gate activity following inflammatory stress.
These experiments build the foundation for testing the hypothesis that myocardial infarction (MI) induces
similar changes to EC gate activity. We will perform sham or MI-surgery on adult mice and examine EC gate
activity by time-lapse intravital microscopy, VEGFR3 signaling in sorted BM endothelial cells and correlate
these findings with flow cytometric analysis of circulating leukocyte levels. We finally propose to test the
contributions of VEGFR3 signaling in the context of MI by investigating EC gate activity in mice lacking
endothelial VEGFR3 or mice pre-treated with VEGFR3 inhibitor. This work proposes to investigate novel
VEGFR3-dependent mechanisms that regulate leukocyte release from the BM following CVD-induced
inflammatory stress and to test whether modulation of this pathway may inform future therapeutic interventions.

Public health relevance
Heart disease is the leading cause of death accounting for nearly 1 of every 4 reported deaths in the US with a heart attack occurring every 40 seconds. Our lab has demonstrated that different models of heart disease remodel the bone marrow vasculature to facilitate the release of immune cells from the marrow which travel to the heart damaging tissue and inhibiting proper repair. The focus of this proposal is to understand the precise mechanism by which cells leave the bone marrow through the vasculature following cardiovascular stress and whether targeting of a specific signaling pathway, VEGF/VEGFR3, that is unique to the bone marrow vasculature may attenuate this inflammatory cascade.